Liquid Biopsy in Myeloma to Inform Outcome and Treatment Decisions

Project Summary
Although effective therapies exist in many cancers, an initial response to therapy is often followed by relapse.
An extreme example is multiple myeloma, a plasma cell malignancy in the bone marrow, which responds to
treatment in almost all patients, but which cannot be cured. Myeloma patients therefore receive many different
lines of therapy during the course of their disease. Repeated bone marrow biopsies are crucial for monitoring
of treatment response and for informing the optimal choice of treatment and are therefore currently
recommended with any change in treatment. However, the excessive number of biopsies over time creates an
enormous burden for patients, and these tissue biopsies are often not performed beyond initial diagnosis. In
addition, bone marrow biopsies only capture myeloma cells from a single site, and therefore do not provide a
complete representation of the heterogeneity and ongoing evolution of this multifocal disease that is
characterized by patchy bone marrow involvement. It is therefore imperative to develop novel approaches that
allow to frequently assess myeloma evolution during therapy and choose those treatments that are most
efficacious. We are proposing to use novel “liquid biopsy” approaches to replace bone marrow biopsy by
interrogating circulating myeloma cells and cell-free DNA in myeloma patients, obtained from a simple blood
draw. We hypothesize that liquid biopsy provides more comprehensive and clinically relevant insights into the
molecular dynamics and genomic evolution of myeloma than can be obtained through single-site bone marrow
biopsies. To accomplish this task, we have pioneered technologies for highly sensitive isolation and deep
molecular and genomic characterization of circulating multiple myeloma cells (CMMCs) with single cell
resolution, as well as whole genome and targeted sequencing of cell-free DNA (cfDNA). We will leverage these
technologies to inform clinical decision-making in a way that is impossible with the current practice of using
bone marrow biopsies as standard-of-care. Specifically, we will demonstrate that: 1) Liquid biopsy is a better
predictor of survival than parameters currently used in clinical routine, 2) Liquid biopsy has greater sensitivity
and specificity to detect established prognostic and predictive genetic disease variants than bone marrow
biopsy, the current gold-standard, 3) Liquid biopsy provides a therapeutically more relevant representation of
the clonal composition and actionable treatment targets of myeloma than bone marrow biopsy, 4) Liquid biopsy
outperforms bone marrow biopsy in determining minimal residual disease (MRD) status. Importantly, replacing
repeated invasive biopsies with liquid biopsy from a simple blood draw will dramatically reduce risk and
discomfort for patients. We expect that the concepts we are investigating will be practice-changing for the care
of myeloma patients and will be broadly relevant across many different cancers and produce important new
opportunities for therapies.

Public health relevance
Project Narrative Finding the most effective therapies for cancer patients is critically dependent on having detailed genomic and molecular insights into the cancer, which currently is only possible by tissue biopsy. Using multiple myeloma as an example of an incurable cancer we are seeking to demonstrate that liquid biopsy of circulating cancer cells and cell-free DNA can replace tissue biopsy and additionally yields clinically actionable information to inform treatment decisions. In this project, we will employ innovative technologies with the goal to establish multimodal liquid biopsy as a comprehensive longitudinal biomarker and practice-changing standard that eliminates the need for tissue biopsy.